Validating an animal model of female veteran risk factors for postpartum depression

Postpartum depression (PPD) is a major depressive episode following childbirth that
affects 10-15% of women in the general population but nearly 20-40% of female veterans.
Current preclinical models of PPD focus solely on civilian risk factors, incorporating single
exposures to either gestational or postpartum stress, postpartum hormone withdrawal, or
genetic manipulations to investigate underlying mechanisms of PPD. Female veterans
have increased exposure to traumatic stressors during their compared to civilian
counterparts and face unique stressors upon leaving the military, including significantly
increased divorce rate, homelessness, and social isolation. This multitude of exposures
represents a key difference from civilian women and may explain the increased PPD rate,
as chronic stress exposure is a major risk factor for PPD. This project proposes to validate
a new rodent model of PPD (multi-CUS) that mimics the traumatic stress exposures
experienced by female veterans. Female rats will be exposed to three weeks of chronic
unpredictable stress, followed by mating. On gestational day 10, females will undergo an
additional 10 days of stress. During the postpartum period, depressive-, anxiety-like, and
maternal behaviors will be assessed and compared to single, gestational CUS-exposed
females as well as non-stress postpartum, and non-pregnant stressed females. Multi-
CUS will also be validated at the cellular and molecular levels via examination of plasma
corticosterone, hormone, and cytokine levels, brain mitochondrial function, and changes
in hippocampal spine density. These are all measures that have been demonstrated in
validated models of PPD. The lack of preclinical PPD models based on female veteran
exposures means that the consequences of these exposures to veteran health are
unknown, posing a health risk to a growing VA healthcare population. This has potentially
devastating consequences as PPD in civilians can lead to lifelong recurring depression,
negative outcomes for offspring, and even suicide. As female veterans have higher
reports of suicide ideation and mental health disorders, they are at an increased risk for
negative outcomes from PPD. Successful validation of the multi-CUS model will allow for
future use of this model to identify how female veteran exposures may alter PPD
symptoms, duration, and treatments.

Public health relevance
Female veterans are the fastest growing demographic in the Veteran Affairs healthcare system. Female veterans face multiple unique risk factors for postpartum depression, including traumatic stress exposure prior to leaving the military, combat exposure, and post-deployment stressors, including social isolation. Consequently, they exhibit over double the rate of postpartum depression compared to civilian women. Understanding the long-term consequences of these exposures to female veteran health will aid in the treatment and possible prevention of postpartum depression in veterans.